Regulation of efferocytosis in the brain following traumatic injury

PROJECT SUMMARY
Neuroinflammation and neuronal apoptosis are hallmarks of traumatic brain injury (TBI). Efferocytosis is a
coordinated process where phagocytes remove apoptotic cell debris to resolve inflammation and begin tissue
repair. However, a prolonged or excessive inflammatory response impairs efferocytosis, leading to delayed
tissue recovery. The regulation of this process has not been evaluated following brain trauma, and its impact on
injury outcomes is yet to be established. Our previous studies, using a controlled cortical impact (CCI) mouse
model of TBI, showed evidence for apoptotic cell engulfment by both resident microglia and peripheral-derived
macrophages (PDMs), the two ontogenetically distinct phagocytes present in the brain acutely after trauma. We
also observed that an augmented peripheral inflammatory response impedes the clearance process. Initial
findings revealed an upregulation of the efferocytosis receptor, MERTK, in both microglia and PDMs, suggesting
its potential regulatory role in efferocytosis during brain injury. Additionally, we noted increased plasma levels of
soluble MERTK (sol. MERTK), indicating the extracellular domain shedding of this receptor, which might restrict
efferocytosis following CCI injury. The objective of this research application is to investigate the temporal
course of efferocytosis by both microglia and PDMs in the acute, subacute, and chronic stages of brain injury
and to determine the role of MERTK in regulating this process and controlling TBI outcome. We hypothesize
that MERTK mediates efferocytosis in acute brain injury, and the cleavage of this receptor restricts the clearance
process, delaying functional recovery. We will first employ a GFP bone marrow (BM) chimeric mouse model to
distinguish the temporal efferocytosis response of PDMs from microglia (Aim 1). Then, we will determine the role
of MERTK in regulating efferocytosis using Cx3cr1CreER-Eyfp/+Mertkf/f to induce conditional deletion of Mertk in
Cx3cr1-expressing cells (including microglia and PDMs), and MertkY867F/Y867F mutant mice, to specifically inhibit
MERTK phagocytosis signaling (Aim 2). Finally, we will determine if MERTK-cleavage restricts the ability of
PDMs and microglia to clear apoptotic debris efficiently and delays the functional recovery following TBI. We will
employ MERTK cleavage-resistant (MertkCR/CR) mice to generate BM chimeric mice (Mertk-WT+Mertk-CR/CR BM Cells
and Mertk-CR/CR+Mertk-WT BM Cells) and parse out the peripheral and central role of MERTK-cleavage on TBI
outcomes. Additionally, we will transfer MertkCR/CR macrophages, which retain MERTK function under cleavage-
promoting conditions, into injured WT mice and assess their impact on apoptotic debris clearance and TBI
outcomes after infiltrating damaged tissue (Aim 3). These studies will advance our understanding of efferocytosis
regulation mechanisms, revealing novel therapeutic targets and identifying the optimal timeframe for treatment
to mitigate secondary injury and behavior deficits after brain trauma.

Public health relevance
PROJECT NARRATIVE The proposed study focuses on clearing cell debris from the brain after trauma through a process known as efferocytosis, an important understudied area of brain research. Our overall goal is to improve the understanding of efferocytosis-mediated inflammation resolution and how this impacts the pathological and behavioral outcomes of traumatic brain injury. New insights into the mechanism(s) that may enhance this important immune response will advance treatment strategies to reduce cognitive and motor deficits following brain trauma.